Research Experience and Training Coordination Core (RETCC)

Abstract
Environmental health science problems posed by chemical exposure are complex; addressing these problems successfully requires expertise from many scientific fields. The Duke University Superfund Research Center (DUSRC) focuses on research and problem-solving in the context of early-life exposures and co-exposures, later-life consequences, and site remediation. Cross-disciplinary training can enable the transdisciplinary research required to solve such problems. Likewise, communicating science is challenging for many scientists, and historically much environmental health science work has been done in the absence of interaction with affected communities. To support trainees in DUSRC work and in preparing themselves for future environmental science and health careers, the Research Experience and Training Coordination Core (RETCC) of the DUSRC provides cross-disciplinary training to trainees to enable them to carry out and communicate integrated, transdisciplinary, problem-oriented research.
The RETCC will provide a flexible and rigorous program characterized by two complementary Aims. First, all trainees will participate in a core set of activities that will ensure proficiency in fundamental knowledge and skills (Aim 1). Second, all trainees will be guided in choosing individually-tailored training activities to provide depth and specificity to career and research field development (Aim 2). These components have been carefully designed to complement the training components of the other departments and programs with which our trainees are associated, including social, biomedical, engineering, and statistical environmental sciences, thus ensuring that the cross-disciplinary training we provide is complemented by in-depth, focused disciplinary rigor.
Specific Aim 1. Provide training in common, fundamental cross-disciplinary knowledge and skills related to environmental health and environmental science and engineering. Required participation in these five activities creates a solid, broad base of cross-disciplinary knowledge and skills for all trainees, stimulates transdisciplinary research, and promotes community among all DUSRC members.
Specific Aim 2. Provide structure and activities that facilitate scientific depth and personalized career development. To complement the broad exposure and proficiencies that all trainees will attain under Aim 1, we will provide a flexible menu of opportunities that will be tailored to the goals and needs of each trainee. Of significance in our renewal application is the redesign of our “mentored mentoring” program, which aims to increase our trainees’ experience with and ability to mentor undergraduate and masters-level students.
As in the last funding cycle, we expect to support 5-7 trainees per year, with an approximate distribution of 75% PhD students, 20% postdoctoral researchers, and 5% Master’s students.

Public health relevance
Project Narrative Environmental health science problems posed by chemical exposure are complex; addressing these problems successfully requires expertise from diverse scientific fields. Likewise, communicating science is challenging for many scientists, and historically much environmental health science work has been done in the absence of interaction with affected communities. The Research Experience and Training Coordination Core of the Duke University Superfund Research Center is dedicated to training future environmental health researchers from many backgrounds in a cross-disciplinary fashion that enables them to carry out and communicate integrated, problem-oriented research, in partnership with affected communities.